Mechanistic Link of ER Stress and Neuroinflammation Following Pyrethroid Exposure

Endoplasmic reticulum (ER) stress and neuroinflammation have been involved in the
pathogenesis of neurodegeneration and cognitive dysfunctions in aging and neurodegenerative
diseases. When robust, sustained levels of ER stress are sensed by cells, UPR function is
impaired and activation of inflammatory and apoptotic pathways are triggered, which
consequently leads to chronic and persistent neurodegeneration and impairment of adult
neurogenesis. Exposure to environmental toxicants, including pesticides have been shown as
causative agents of ER stress, and neuroinflammation associated with neurodegeneration and
neurological diseases. Pyrethroids are the most widely employed group of insecticides to control
pests in public health, agriculture, and residential settings. Importantly, cognitive impairment has
been reported in adults occupationally exposed to pyrethroids. In previous studies, we have
shown that repeated pyrethroid exposure induced ER stress, apoptotic cell death, disruption of
hippocampal neurogenesis, and learning and cognitive deficits in adult mice. Recently, we
reported that pyrethroid insecticides activate microglia and increase production of major
inflammatory mediators TNF-α and ROS in microglial cells and that repeated adult exposure to
deltamethrin causes oxidative stress and neuroinflammation in the hippocampus of adult mice.
These results suggest that ER stress-mediated neuroinflammation may be a primary mechanism
by which deltamethrin impaired hippocampal neurogenesis and cognitive dysfunction following
deltamethrin exposure. Here, we will determine the weather inhibition of ER stress attenuates
neuroinflammation in the hippocampus in mice following deltamethrin exposure.

Public health relevance
The student will be gaining valuable knowledge and experience in the environmental health sciences research during this summer through this project, which will benefit his college application as well as future studies for masters and PhD.